Relation of individual differences in fMRI-Assessed Satiation Signaling to Obesity Risk and Future Weight Gain

SUMMARY
Obesity affects 2.8 billion people worldwide and is the second leading cause of premature mortality.
Unfortunately, current treatments do not produce lasting weight loss, potentially because of an incomplete
understanding of the risk processes that promote obesity. After eating to fullness individuals with obesity
versus without obesity show weaker satiation signaling, as indexed by elevated responsivity of reward
valuation and gustatory regions in response to food cues and food tastes and stronger connectivity between
these brain regions. Behaviorally, obesity is associated with consumption of excess calories ab libitum when
sated, along with reduced perceived fullness and less perception of homeostatic signals during satiation.
Although research has established that obesity is correlated with weaker satiation signaling, no study has
determined whether weaker satiation signaling increases the risk for future overeating and weight gain or is a
consequence of overeating. Thus, we propose to conduct a rigorous prospective study designed to determine
the direction of influence between these two variables. We will recruit 132 healthy-weight adolescents (aged:
13-16; n=80 at high risk for obesity virtue of maternal obesity) for a multimodal, repeated-measures study
using a novel fMRI paradigm designed to capture neurobehavioral changes over the course of eating to
satiation. We will also include objective measures of body fat, food intake, gut hormones, and cognitive
measures. Aim 1: We will a) test the hypothesis that over the course of eating to satiation healthy-weight
adolescents at high-risk versus low-risk for obesity (virtue of maternal obesity) will show persistently elevated
brain response to energy-dense food tastes in the striatum, postcentral gyrus, and gustatory cortex. Aim 2: We
will a) test the hypothesis that participants who show weaker satiation signaling, as evidenced by persistently
elevated responsivity in the striatum, postcentral gyrus, and gustatory regions after eating to fullness will show
elevated future body fat gain over a 3-year follow-up, and b) test the ability of individual differences in a
satiated brain fingerprint to predict future body fat gain over a 3-year follow-up. Aim 3: Test the hypothesis that
the degree of percent body fat gain at 3-year follow-up will be related to a reduction in satiation signaling, as
indexed by a) higher responsivity in striatal, postcentral gyrus, and gustatory regions after eating to fullness
over the course of satiation, and b) increased engagement of these regions in a brain fingerprint when satiated.
If data provide support for Aims 1 and 2, but not Aim 3, results would suggest that weaker satiation signaling
increases risk for weight gain. In contrast, if data provide support for Aim 3, but not Aim 1 and 2, results would
suggest that weaker satiation signaling is a consequence of overeating. Finally, if data provide support for all 3
Aims, results would suggest that weaker satiation signaling increases risk for overeating and weight gain, and
further that this overeating further attenuates satiation signaling in a dynamic feed-forward fashion.

Public health relevance
NARRATIVE Individuals with obesity versus without obesity show evidence of weaker satiation signaling, however, research has yet to determine the direction of influence between obesity and weaker satiation signaling. The proposed study will test whether healthy weight youth at high-risk for obesity show weaker neural satiation signaling than low-risk youth (Aim 1), test whether youth who show weaker neural satiation signaling will show elevated future weight gain (Aim 2), and the impact of percent body fat gain at 3-year follow-up on the possible reduction in satiation signaling (Aim 3). This study can determine whether weaker satiation signaling is an initial vulnerability factor for weight gain, is the result of habitual overeating, or is dynamically related in a feed- forward fashion; an improved understanding of risk processes for obesity should guild the design of more effective prevention programs and treatments.